Using Metabolomics to Understand CVD Risk in Women with a History of Preterm Delivery

Project Summary/Abstract
Background: Cardiovascular disease (CVD) is the leading cause of mortality in both women and men.
Preterm delivery (PTD) occurs in 10% of US pregnancies and is associated with twice the risk of long-term
CVD morbidity and mortality in mothers. Only 13-17% of the association between PTD and CVD is explained
by subsequent development of established cardiovascular risk factors such as hypertension, diabetes,
hyperlipidemia and obesity. Our poor understanding of the physiologic pathways from PTD to CVD limits our
ability to use PTD as an `early warning system' to better prevent and treat CVD in women. The goal of this
project is to expand our understanding of PTD and CVD through discovery and validation of metabolomic
signatures and scores among women with a history of PTD, confirming their association with CVD events and
performing mediation analysis. We will also examine the association of PTD clinical phenotypes with CVD.
Setting: We have assembled an exceptional team with deep expertise in CVD, pregnancy exposures,
metabolomics, and biostatistics/ bioinformatics. Investigators on this project have decades of experience
studying CVD, pregnancy complications, and metabolomic epidemiological studies. This application will
leverage U01-funded infrastructure and biosamples of the Nurses' Health Study (NHS) 2 and 3 cohorts, as well
as CVD outcomes and previously measured metabolomic profiles in NHS1 and the Women's Health Initiative.
Research Plan: We will measure metabolomic profiles in 1500 women, including 400 women with a history of
PTD, and 400 parous women with no preterm deliveries. Metabolomics will be performed at the Broad Institute.
Using a robust methodology of discovery and validation, we will: 1) Discover and validate metabolomic
profiles and PTD metabolite (M-PTD) scores for midlife women with a history of PTD (NHS2/3). PTD
phenotypes to be examined: a) Total PTD; b) Clinical PTD: Preterm prelabor rupture of membranes,
spontaneous preterm labor with intact membranes, medically-indicated PTD; c) Timing of PTD: <32 weeks, 32-
<37 weeks; Exploratory: Agnostically derived metabolite endotypes of PTD; 2) Examine the association of
clinical PTD phenotypes with CVD incidence (NHS2 full dataset); 3) Test the association of M-PTD
scores with incident CVD (NHS1, NHS2, WHI) and determine mediation of the observed increased CVD
risk from PTD metabolites (NHS2). Relevance to Public Health: CVD is an issue of major public health
importance. The proposed analyses have the potential to identify precursors and pathways integral to CVD
incidence after PTD, a female-specific cardiovascular risk factor, which may then be used to improve
prevention strategies, enhance treatment options, and generate additional testable hypotheses that will guide
future CVD research. Our approach leverages decades of prospective data collection in the NHS2 and NHS3
and our strong preliminary data support a high likelihood of success.

Public health relevance
PROJECT NARRATIVE The goal of this study is to improve our understanding of the metabolic consequences and cardiovascular risk profiles of women with a history of preterm delivery. We will achieve this by analyzing a wide panel of metabolites among 1500 women in the Nurses' Health Study (NHS) 2 and NHS3, and identifying metabolite profiles and metabolite scores (M-PTD) for women with a history of preterm delivery in NHS2/3, compared to women with term pregnancies. We will examine the association of these M-PTD scores with cardiovascular outcomes in separate populations, as well as formally test mediation of preterm delivery cardiovascular risk by the M-PTD score. Additionally, we will examine the association of different clinical phenotypes of preterm delivery with cardiovascular outcomes. These data will improve our understanding of underlying mechanisms and pathways that contribute to cardiovascular disease risk in women with a history of preterm delivery.